Adiponectin signaling in mood regulation

DESCRIPTION (provided by applicant): Depression is a severe and common mental disorder and often coexists with metabolic disorders such as diabetes. Therefore, the identification and characterization of therapeutic targets that are potentially beneficial for the treatment of both depression and diabetes would be of great clinical significance. Adiponectin, a hormone secreted almost exclusively by white adipose tissue, is well recognized as an anti-diabetic adipokine. We have demonstrated that adiponectin insufficiency increases susceptibility to depression-like symptoms. By contrast, administration of exogenous adiponectin to the brain produces antidepressant-like effects in normal weight mice and in obese diabetic mice, suggesting a critical role for adiponectin in depressive-like behaviors. The goal of this project i to define the molecular and cellular mechanisms of adiponectin actions on depressive behaviors. Adiponectin receptors, AdipoR1 and AidpoR2, display distinct expression patterns in the hippocampus and medial prefrontal cortex (mPFC), two key brain regions implicated in depression and the therapeutic actions of antidepressants. Central injection of adiponectin induces neuronal activation and stimulates p38MAPK, an upstream activator of the inhibitory phosphorylation site of GSK-3b. Moreover, adiponectin has been shown to stimulate hippocampal neurogenesis in vitro. Based upon these findings, we hypothesize that adiponectin regulates depressive behaviors in a brain-region, receptor-specific manner through distinct molecular and cellular mechanisms. We propose to determine the region-specific roles of AdipoR1 and AdipoR2 in the development of depressive-like behaviors and in mediating the antidepressant-like effect of adiponectin, identify the signaling cascade that mediates actions of adiponectin on depressive-like behaviors, and determine whether neurogenesis contributes to the behavioral effect of adiponectin. These studies will provide novel insights into adipokine regulation of mood-related behaviors and lead to the development of novel therapies for depression.

Public health relevance
PUBLIC HEALTH RELEVANCE: Depression is a highly prevalent mood disorder and is often associated with other medical conditions. Individuals with diabetes are at significantly greater risk for developing depression. Therefore, it is of clinical significance to identify novel therapeutic targets with beneficial effects on both depression and diabetes. The studies proposed in this project will enhance our understanding of the pathogenesis of depression and provide a potential novel treatment strategy for depression, especially for treating depression comorbid with diabetes.